Biology, Bioinformatics & Chemistry Academy for Research Scholars (B2-CARS): A Partnership to Address Human Health Through Waste Water Remediation

Abstract
This application requests support for B2-CARS, two 2-week, residential summer enrichment programs (two
cohort of students) at Delaware State University that combines hands-on explorations in chemistry, biology,
and bioinformatics with laboratory research activities through the lens of natural resources. This project
will offer 32 motivated middle school students from under-represented groups an opportunity to integrate
and apply concepts from these disciplines to problem solving. The long-term goal of the project is to
increase the number of minority students and women entering college majoring in science, technology,
engineering and mathematics (STEM), thereby addressing the problem of under-representation of
minorities in these fields. Our goal in this project is to enhance our participants’ educational experience in
a way that increases their enjoyment of and comfort with STEM, and helps them understand and solve
problems in a broad array of disciplines including life science and medicine. We expect that the B2-CARS
experience will encourage and prepare participants to move forward to college majoring in STEM
disciplines and increase their awareness of the importance of protecting natural resources.